The roles of genetics, hormones, and gender in sexually dimorphic immune response

ABSTRACT
Sex and gender contribute to the immune system and how we as humans respond to foreign infections. Males
traditionally have an elevated risk of hospitalizations due to infections from birth to old age. Females, however,
have a more protective immune system, yet have an elevated risk of autoimmunity. Thus, the balance between
fighting infections and limiting immune response is stratified. Animal models have allowed us to largely tease
out the role of sex chromosomes and hormones (such as estrogen/testosterone), but they lend little insight into
the role of human gender on the immune response. Disparities between trans- and cis-gender women are
observed in multiple inflammatory and immune phenotypes, from HIV risk to rheumatological conditions. As
gender is a non-binary spectrum, many precision medicine tools can be applied to tease out individuals’
immune system modulators focused on individual assessments of sex chromosomes, sex hormones, and
environmental factors. To do this, we have compiled a multiple PI team that brings strengths from
epigenetics/epidemiology (Dr. Triche), infectious disease modeling (Dr. Krawczyk), and sex
chromosome/hormone genetics (Dr. Prokop). We highlight in this work how the histone methylation regulator
chromosome pair, KDM5C (chrX) and KDM5D (chrY), results in an immune modulation through genome-wide
epigenetic alteration.
We have developed three complementary aims to build an integrated model of KDM5C/KDM5D influence on
individuals’ immune responses. Aim1) Genetics of KDM5C hematopoiesis conditional knockout alteration at
the cellular resolution of the immune system following a chronic viral infection, allowing us to determine cell
types and global epigenetic alterations regulated by the pathway. Aim2) Precision insights for KDM5C/KDM5D
of ~20,000 human blood samples following various immune challenges and the separation of hormone and sex
chromosome using the four-core genotypes rodent model blood single-cell data generation. Aim3) Integrating
our knowledge to individuals for human variants, gene regulation, environmental modulation, and phenotypic
associations for KDM5C/KDM5D. The combination of the three aims represents a precision medicine
approach, allowing us insights into the cells and pathways impacted by the sex chromosome genes during
infection (Aim1), deconvolution of how hormones and sex chromosomes synergistically contribute to immune
cells (Aim2), defining the broad infections and signatures that modulate the genes (Aim2), and integrating this
knowledge to be applied to any individual in a non-binary approach (Aim3). As gender can never be binned
into groups, with an undefined spectrum of individuals within, we lay forth a novel, innovative way for thinking
about how sex and gender both contribute to immune systems without the need for defining gender but
allowing for individualized assessments.

Public health relevance
PROJECT NARRATIVE Sex and gender differences are a combination of genetics, sex hormones, and other environmental regulators. In this work we explore how sex hormones and environmental regulation interact with variants on the sex chromosomes to impact the immune system and response to various viral and bacterial infections. To do this, we integrate a mouse model of genetic editing of the sex chromosome that is exposed to chronic infection with large scale data analysis of rodent and human sex and gender contributions to the immune system.